COSTS OF HEALTH SERVICES FOR HIV INFECTED INDIVIDUALS

This project extends and expands on an initial investigation based on Medicaid paid claims files to (1) confirm on an expanded and more complete data set the male/female differential in HIV-related health services utilization; (2) measure the impact of AZT usage on average monthly payments over time; (3) investigate the apparent underutilization of health services by 20% of persons with HIV related causes of death; (4) explore the health services utilization by HIV-infected mother-child dyads; (5) examine possible six month cycles of health services utilization; (6) investigate possible health services utilization and cost differentials for HIV infected individuals, with and without substance abuse problems. We will also validate our approach to differentiating between HIV- related and unrelated health care by examining the medical records of 30 HIV-infected individuals. We will also request 100 hospital discharge abstracts form a sample of Detroit area hospitals, to confirm with greater diagnostic detail the judgment made concerning the initiation of HIV-related health services utilization.